VesiVax Vaccine Formulation Against Neisseria gonorrhoeae

Project Summary
The principal goal of this project is to develop a VesiVax®-based vaccine against Neisseria
gonorrhoeae (Ng). The studies proposed in this SBIR Phase I application will be focused on co-formulating an
newly identified surface-displayed outer membrane Ng protein, MtrE, with various immunostimulatory adjuvant
molecules (IAMs) in the VesiVax® liposomal platform. We will characterize the immunogenicity of these
VesiVax®-MtrE-IAM formulations in mice, and select for the best candidates to be further evaluated in a novel
mouse upper reproductive tract Ng infection model. These studies will elucidate the immunological profile in a
vaccine that will correlate with protective immunity against Ng.

Public health relevance
Public Health Relevance The principal objective of this project is to develop a liposomal vaccine formulation against gonorrhea, a sexually transmitted disease that still represents a significant public health threat in the United States and the world. Gonorrhea is one of the most frequently diagnosed sexually transmitted diseases, and the impact of gonorrhea is expanded by the increased risk of human immunodeficiency virus (HIV) infection and transmission among individuals infected with gonorrhea. As the antibiotic resistance in gonorrhea is growing, the need for an understanding of the criteria needed for protective immunity against gonorrhea and the development of an effective vaccine is apparent.